Pharmaco-epidemiology of diabetes in patients with end-stage kidney disease

Project Summary
Diabetes is a leading cause of end-stage kidney disease (ESKD), with about 55-600% of patients on dialysis
having diabetes. Glucose management in the context of dialysis is challenging. In recent studies, we reported
that patients with diabetes and ESKD have increased risk of severe hypoglycaemia and hyperglycemic crises.
However, there is lack of contemporary, nationwide data about how diabetes is managed among these
patients, and how each treatment regimen may impact the risks of acute preventable complications (e.g.,
severe hypoglycaemia and hyperglycemia) and health outcomes (e.g., readmissions, mortality). Similarly, it is
unknown whether there is a relationship between specific anti-diabetic agents or insulin formulations and the
rates of diabetes crises among minority groups, such as African Americans and Hispanics, which are
disproportionately affected by diabetes and ESKD. In this observational study, we propose to use the most
comprehensive database of patients with ESKD, the United States Renal Data System to (aim 1) characterize
contemporary, real-world patterns of glucose-lowering therapy and diabetes technologies in this population,
which may diverge from what is recommended in clinical guideless or explicitly studied in clinical trials. We will
also (aim 2) examine health-related outcomes, specifically all-cause and cause-specific (i.e., for hypoglycemia,
hyperglycemia) hospitalizations, readmissions, and mortality, as a function of glucose-lowering regimens (e.g.,
human and analog insulin, GLP-1 receptor agonist, DPP-4 inhibitor). Our analyses will also evaluate for
differences by diabetes type and for disparities based on patient’s race/ethnicity and sex. We anticipate
identifying the most vulnerable subgroups and treatment agents associated with higher risk of acute glycemic
complications, which will have downstream impacts such as translational research trials and management
recommendations. With support from a K23 grant (5-K23DK123384-04), Dr. Galindo is currently assessing if
(aim 1) a novel, factory-calibrated, continuous glucose monitoring (CGM) system can provide better
assessment of glycemic excursions compared to the standard-of-care using capillary glucose testing, and (aim
2) if using real-time CGM will prevent hypoglycemic events among patients with diabetes and ESKD on dialysis
using insulin therapy, and provide better overall glycemic control. Findings from this study R03 study, coupled
with findings from my K23 prospective study, will have strong clinical and translational impact, and will be used
to design randomized trials focusing on de-escalating or tailoring patient-centered efficacious and safer anti-
diabetic regimens, using an improved glycemic monitoring systems (e.g., CGM) for this high-risk group in
subsequent R01 applications.

Public health relevance
Project Narrative There is no contemporary, nationwide data about how diabetes is managed among people with diabetes and end-stage kidney disease, and how this affects the risks of health-related outcomes (mortality, readmissions, hospitalizations) and severe hypoglycemia and hyperglycemia crises -common yet potentially preventable events in this high-risk population. This proposal will leverage expertise (secondary data analysis, health- outcomes research) of a multi-disciplinary research team and the most comprehensive nationwide database of patients with ESKD, the United States Renal Data System (USRDS), to characterize contemporary patterns of glucose-lowering therapy and diabetes technologies among patients with diabetes and ESKD; quantify rates of all-cause and cause-specific hospitalizations/emergency department visits (severe hypoglycemia and hyperglycemia), mortality, and readmissions, as a function of each glucose-lowering therapy. These results will have strong clinical and translational impact on the management of glycemia in the setting of ESKD and will be used to inform prospective trials to support safer treatments in this high-risk population.